The role of noncoding regulatory variants in orofacial clefts

PROJECT SUMMARY
Orofacial clefts (OFCs) are the most common craniofacial birth defect in humans and are caused by multiple
genetic and environmental risk factors. Elucidating the etiology of OFCs is critical not only for our knowledge of
developmental biology and for how clefts arise, but ultimately for improved prevention, treatment, and
prognosis for individuals affected by OFCs. Clinical applications of genome sequencing are growing, but the
usability for OFCs is hindered by a substantial missing fraction of heritable risk and a poor understanding of
how variants in non-coding regulatory elements contribute to OFC risk. These elements include (but are not
limited to) enhancers, promoters, noncoding RNAs (e.g., microRNA), and topologically associated domain
boundaries. Despite the mounting evidence that non-coding regulatory variants are important contributors to
human disease, widespread analysis of such variants in OFCs has been limited by the lack of a large resource
of whole genome sequences in individuals with OFCs and difficulties annotating craniofacial regulatory
variants. In this proposal, we will take advantage of several recent initiatives that directly address these
barriers by analyzing rare de novo, inherited, and structural variants from over 1,300 case-parent trios with
OFCs sequenced through the Gabriella Miller Kids First Research Program. We will integrate these data with
genomic atlases of chromatin profiling, microRNAs, and RNA-seq data generated from human and mouse
craniofacial tissues. These analyses will provide key insights into the genetic architecture of OFCs and will
reveal the full potential of WGS data for OFCs.

Public health relevance
PROJECT NARRATIVE Nonsyndromic orofacial clefts are common birth defects caused by multiple genetic and environmental risk factors. The goal of this study is to comprehensively interrogate genetic variation located within non-coding regulatory elements by analyzing whole genome sequence data from case-parent trios.